Testosterone Therapy for Diastolic Function Recovery in Hypogonadal Elderly

DESCRIPTION (provided by applicant): Several functional and pathologic changes associated with the aging heart result in impaired myocardial relaxation causing significant morbidity and mortality from diastolic heart failure in the elderly. There is a glaring lack of effective therapy for diastolic dysfunction and most pharmacologic trials have shown none or very modest benefits. Bioavailable testosterone (T) levels decline progressively after the 4th decade and interestingly the prevalence of diastolic dysfunction increases across the same age range. Thus, epidemiologic and experimental data suggest a possible association between decreasing T levels and worsening diastolic dysfunction. It is possible that bioavailable T deficiency contributes to the development and/or exacerbation of age-related diastolic dysfunction. Therefore, T replacement may offer an attractive option to alleviate diastolic dysfunction in the elderly. We have confirmed the above proposed relationship by demonstrating development of abnormal global diastolic function (by invasively-measured time constant of relaxation; tau) in gonadectomized rats that was reversed after replacement T therapy. These data corroborate the potential favorable effects of T therapy for treatment of diastolic dysfunction thus introducing a novel indication for use of T therapy in the elderly that would address a highly prevalent clinical problem. We identify two key barriers to the clinical use of T for alleviation of diastolic dysfunction: 1) the lack of knowledge of the optimal T dose for diastolic recovery. Our clinical and experimental data suggest a moderate, rather than low dose, would be more effective, and 2) absence of an imaging biomarker that will track changes in diastolic function. Our extensive work in regional and global diastolic mechanics by echocardiography suggest early diastolic strain rate as a potential biomarker. The overall goal of the proposed T1 Translational proposal is to successfully resolve these barriers and lay the foundation to develop T as a novel therapy for diastolic dysfunction in elderly humans. The work conducted under this proposal will set the stage for a clinical trial of T for treatment of age-related diastolic dysfunction. Specific Aim 1: To determine the optimal T replacement dose in hypogonadal elderly males that will alleviate global and regional diastolic dysfunction. We will compare placebo to 2 doses of T in hypogonadal elderly males (with the aim of restoring T levels to low versus moderate normal ranges) treated for 6 months. We hypothesize that regional and global diastolic strain rate will improve in the moderate T replacement group compared to low T replacement and placebo groups. Specific Aim 2: To establish an accurate and sensitive imaging biomarker(s) able to monitor dynamic subtle changes in diastolic function. We hypothesize that early diastolic strain rate will demonstrate interval changes in regional and global diastolic mechanics. This proposal develops on substantial preliminary data from human subjects and experimental models that support the use of T for reversal of diastolic dysfunction in the hypogonadal elderly.

Public health relevance
PUBLIC HEALTH RELEVANCE: Diastolic dysfunction is highly prevalent in the elderly and contributes to reduced quality of life and survival in this population. Experimental data suggest a possible role for testosterone therapy to reverse diastolic dysfunction and the overall goal of the proposed T1 Translational proposal is to resolve the barriers to the use of testosterone as a novel therapy for diastolic dysfunction in elderly humans. The work conducted under this proposal will set the stage for a clinical trial of testosterone for treatment of age-related diastlic dysfunction. __SpecificAimsTextDelimiter__ Functional and pathologic changes associated with the aging heart result in impaired myocardial relaxation causing significant morbidity and mortality from diastolic heart failure in the elderly.7-11 In community based studies, DD is noted in over 47% of patients over 55 years of age,3 worsens over time with age >65 years being a major factor (odds ratio 2.85) and is associated with heart failure even after adjustment for hypertension, diabetes and coronary disease.12 Yet, there is a glaring lack of effective therapy for DD and most pharmacologic trials have shown none or very modest benefits.13 Bioavailable testosterone (T) levels decline progressively after the 4th decade and interestingly the prevalence of DD rises from the 4th decade and beyond.14, 15 In castrated rats, muscle mechanics studies demonstrate that systolic contraction force is preserved but diastolic relaxation is substantially slower.1, 2 In an aging rat, cellular studies show normal systolic rise in calcium transients but slower fall rates.16, 17 These epidemiologic and experimental data suggest a possible association between decreasing T levels and worsening DD. [It is possible that T deficiency is one of many contributors to the development and/or exacerbation of age-related DD.] However, there was no direct evidence that T deficiency influenced global DD. Our preliminary data show for the first time the development of abnormal global diastolic function (by invasively-measured time constant of relaxation, tau, in gonadectomized rats with low T. Compared to vehicle, replacement T therapy was able to effect diastolic recovery and reverse DD. Therefore, T replacement may offer an attractive option to alleviate DD in the elderly and introduce a novel indication for use of T therapy in the elderly that would address a highly prevalent clinical problem. Modulation of the development and progression of DD in the elderly has the potential to reduce rates of DD and more importantly diastolic heart failure in this population. Heart failure contributes to >$34 billion in direct health care costs in the U.S, alone.18 [In an observational analysis of 415 men enrolled in the Baltimore Longitudinal Study of Aging we found that total and bioavailable T levels correlated significantly with 2 echo-Doppler indices of diastolic function further implicating T in DD.] We analyzed diastolic function data from 27 hypogonadal elderly males randomized to placebo or T replacement for 24 months. Our preliminary data show that there was no change in diastolic function as determined by conventional echo-Doppler variables. These data suggesting an apparent lack of T effect on diastolic function have 3 possible explanations: 1) the T dose was inadequate; 2) the imaging biomarkers were not adequately sensitive to detect subtle diastolic changes, and 3) patient selection bias - many patients had normal or indeterminate diastolic function at baseline - thus demonstrating a difference would be challenging. Successful resolution of these issues would be critical to the development of clinical trial for T therapy for DD in the elderly. The lack of change in diastolic function in the clinical trial at a low replacement dose and our experimental data suggesting a demonstrable change in diastolic function at a higher T dose suggest that a moderate, rather than low replacement ranges, would be more effective for diastolic recovery. Our extensive work in regional and global diastolic mechanics by strain echocardiography indicates that strain-based parameters are superior to conventional echo-Doppler for assessment of diastolic function. Further, our studies in elderly subjects indicate that regional diastolic strain rate patterns were different despite similar global diastolic pattern conventional echo-Doppler evaluation. Lastly, in our experimental model, a mechanics-based time index best correlated with invasive tau values and best reflected changes in diastolic function. The overall goal of the proposed T1 Translational proposal is to develop the foundation to offer T as a novel therapy for DD in hypogonadal elderly. The work conducted under this proposal will provide critical information to plan a clinical trial of testosterone for treatment of age-related DD. Specific Aim 1: To determine the optimal T replacement dose in hypogonadal elderly males that will improve DD, compared to placebo. Hypothesis: Restoration of a critical level of T in hypogonadal elderly will mediate the mechanical changes that drive diastolic function recovery. We will compare placebo to 2 doses of T (to restore T levels to low normal versus mid-normal range) in hypogonadal elderly males treated for 6 months. We anticipate that diastolic strain rate will improve in the mid-normal replacement group versus placebo or low- normal T replacement group. Specific Aim 2: To establish the optimal imaging biomarker(s) that are able to monitor dynamic changes in diastolic function. Hypothesis: [Diastolic strain rate will be a sensitive marker of subtle changes in regional and global diastolic function and superior to conventional Doppler parameters.] We will compare several conventional Doppler, tissue Doppler and strain-based variables of global DD, and global and regional diastolic mechanics. We anticipate that early diastolic strain rate will best depict interval changes in regional and global diastolic function. Both aims will be tested in a select population of hypogonadal elderly demonstrating DD at baseline and randomized in a blinded, placebo-controlled fashion to T therapy versus placebo.